Identifying structural variants influencing human health in population cohorts

Project Summary/Abstract
Large-scale biobank resources of genetic and phenotypic data hold great promise for revealing insights into
disease genetics and enabling genetically-informed, targeted therapeutics. To more fully realize this potential,
new statistical methods are needed to recover latent information about genomic structural variants – i.e.,
polymorphisms modifying >50 base pairs of DNA sequence – within these data sets. Because of their large
size, structural variants collectively contribute more base pairs of variation within an individual’s genome than
single-nucleotide polymorphisms (SNPs) or short indels. However, structural variants have been difficult to
identify and genotype from the SNP-array and short-read sequencing data generated by biobanks to date.
We will undertake a research program to develop a new suite of “haplotype-informed” statistical algorithms
designed to accurately and efficiently genotype structural variants in large biobank data sets. This approach
will leverage the fact that population-polymorphic genetic variants are typically carried by multiple individuals
within a large cohort who co-inherited an extended SNP-haplotype. Identification of such shared haplotypes
will enable information about a structural variant carried by one individual to inform detection of the same
variant carried by other distantly related individuals, simultaneously facilitating structural variant genotyping,
variant harmonization, and haplotype-resolved analysis.
This project will have three specific aims. First, we will develop haplotype-informed computational methods that
improve detection sensitivity and genotyping accuracy for several classes of structural variation using short-
read sequencing data. These methods will be particularly helpful for analysis of short copy-number variants
(CNVs) from exome-sequencing data and for analysis of multi-allelic CNVs and large repeats from exome- or
genome-sequencing data. Second, we will develop methods for imputing structural variants into genotype-
phenotype association data sets – a statistical approach that has been extremely effective in genome-wide
association studies (GWAS) of SNPs and indels but has been difficult to apply to structural variants. We will
develop new methods to impute structural variants from short- or long-read-based reference panels and will
also develop a pipeline for imputing and fine-mapping structural variant associations into GWAS summary
statistics. Third, we will genotype structural variants in multiple large genetic biobank data sets and identify
associated health outcomes. We will return haplotype-resolved structural variant call sets for use by other
researchers. We anticipate that these efforts will reveal new structural variant polymorphisms with large
phenotypic effects, augment existing biobank resources, and enable imputation into further data sets.

Public health relevance
Project Narrative Structural variation within the human genome accounts for the majority of base pairs of variation in each human genome and is known to influence a wide range of human traits and diseases. This proposal aims to discover new structural variants not previously identified by genetic association studies and determine their effects on human health. These analyses will be made possible by developing new computational methods that integrate data across distantly related participants in biobank cohorts who share co-inherited mutations.